HIV immune evasion and escape through T cell virological synapses

Summary
Understanding the conformational states of the HIV Envelope (Env) protein that bNAbs target is critical
because these are most effective at blocking infection. Env is Translated as a 160 kD precursor, cleaved, and
glycosylated in the Golgi before being trafficked to the cell surface, where it is incorporated into virus particles
and participates in cell-cell infection. During its production Env is cleaved by furin-like proteases from an initial
metastable gp160 precursor trimer, into a mature, cleaved gp120-41 protein. Cleavage is inefficient; thus, both
cleaved and uncleaved Env can be found on the cell surface. Fully cleaved Env, which assumes a stable
conformation (called State 1), is selectively incorporated onto viral particles. In addition, bNAbs primarily target
state 1 Env. Studies have not been able to isolate mixed Env, which have both cleaved and uncleaved protomers.
These Env are asymmetric in conformational state and we study them here. We speculate that incompletely
processed Env trimers are sent to the endocytic recycling compartment and back to the Golgi for further
processing and that only fully processed forms of Env are routed to the nascent virus particle. Understanding
the mechanisms that enable recognition of only processed Env for incorporation into the virus particle can help
us understand how cell-to-cell infection resists neutralizing antibodies. In this project, we will characterize the
mechanism for sorting cleaved Env onto viral particles, by generating asymmetric and homogenous Env trimers
and study the conformational changes and trafficking of Env engaged in cell-free and cell-to-cell infection. We
hypothesize that the partial cleavage of Env results in asymmetry of Env trimers, providing a signal recognized
by host machinery that “marks” Env as not “ready” to be packaged onto virus particles; thus, forcing Env to
undergo further processing through endocytic recycling. Establishing cleavage state as a selection marker will
help us understand the difference between viral and cell surface Env; therefore, enabling the development of
bNAbs that can recognize these differences.

Public health relevance
Narrative We will study whether partial cleavage of Env on individual trimers results in asymmetric gp160/gp120 heterotrimers that may mark Env as excluded from packaging onto virus particles. By studying the impact of uncleavable forms of Env on non-mutant Env forms, we will study the impact of asymmetric Env trimers on the preferential sorting of cleaved Env to virus particles.